Improving Rates of Diagnostic Colonoscopy in Native Americans through a Culturally Sensitive Digital Outreach Intervention

PROJECT SUMMARY
Native Americans (NA) endure a disproportionate burden of colorectal cancer (CRC) incidence and CRC-specific
mortality. Screening is an effective early detection strategy to decrease preventable CRC-related deaths, but NA
have some of the lowest CRC screening rates. In Oklahoma, only 51% of NA are up to date with screening
compared to nearly two-thirds of eligible US adults. Efforts to reduce disparities in screening rates have focused
on increasing access to home stool screening. However, approximately one-half of NA in Oklahoma with an
abnormal home stool test do not complete a required follow-up diagnostic colonoscopy. As time to colonoscopy
after an abnornal home stool test is associated with greater diagnosis of late-stage disease and CRC mortality,
innovative strategies are needed to increase rates of timely diagnostic colonoscopy follow up among NA in
Oklahoma. The proposed study leverages an existing relationship with the Cheyenne and Arapaho Tribes to co-
develop and pilot test two digital outreach interventions to increase rates of diagnostic colonoscopy. First, mobile
health outreach (mHealth; SMS text and video messages) will attempt to increase motivation to schedule a
diagnostic colonoscopy. In addition to receiving informational texts about how and why to schedule a
colonoscopy, participants will also receive culturally sensitive videos that use personal narratives from NA
patients and other high-status Cheyenne and Arapaho Tribal members (e.g., elders). Second, current clinic
workflow requires Cheyenne and Arapaho patients to visit the colonoscopy clinical facilities for both a pre-visit
appointment and the actual procedure. This process requires a minimum of two round trips to a colonoscopy
facility of over 90 miles for most patients. We will test whether a pre-visit telehealth consultation reduces
transportation barriers. Our overarching hypothesis is that culturally sensitive digital outreach intervention will
increase motivation, reduce structural barriers, and, thus, improve rates of diagnostic colonoscopy. The first
study aim will co-develop and integrate culturally sensitive digital outreach intervention strategies into clinic
workflows, guided by NA patients and a community advisory board. Among 140 NA patients, the second aim will
determine reach, feasibility, and potential efficacy of intervention strategies using a 2 x 2 factorial design:
(Outreach Type, Factor 1) mHealth outreach vs. informational pamphlet; (Consultation Type, Factor 2) telehealth
vs. in-person pre-visit colonoscopy consultation. The primary outcome is potential efficacy, measured as rates
of diagnostic colonoscopy 60 days post-randomization. The third aim will explore penetration, acceptability, and
scalability of digital outreach intervention strategies. If effective, this first-of-its-kind and highly scalable approach
offers a substantial public health impact to reduce avoidable CRC morbidity and mortality among NA patients by
increasing rates of diagnostic colonoscopy. Findings will support an R01 Hybrid Type 1 effectiveness-
implementation trial to determine clinical effectiveness and better understand context for implementation of
culturally sensitive digital outreach interventions across our Tribal partners in Oklahoma.

Public health relevance
PROJECT NARRATIVE Native Americans in Oklahoma endure a disproportionate burden of colorectal cancer incidence and colorectal cancer-specific mortality, which is partly explained by poor rates of follow-up diagnostic colonoscopy after an abnormal home stool test. The proposed study aims to co-develop and pilot test a culturally sensitive digital outreach intervention to increase motivation, reduce structural barriers, and, thus, improve rates of diagnostic colonoscopy. This study offers a substantial public health impact to reduce avoidable CRC morbidity and mortality among Native Americans, and will provide valuable insight on how to scale culturally sensitive digital outreach interventions across our Tribal partners in Oklahoma.